Administrative Core

Project Summary/Abstract
Administrative Core
Yale Cooperative Center of Excellence in Hematology
The Administrative Core of the Yale Cooperative Center of Excellence in Hematology will provide the
administrative structure and support for activities of the YCCEH. Activities of the Administrative Core include all
administrative and supervisory functions of the YCCEH and its administrative leadership, and the organization
and supervision of Core facilities, as well as the planning and scheduling of the enrichment programs. All fiscal
records and accounts for the Cores are maintained by the administrative core and are distributed to Core
Directors on a regular basis. The Core provides administrative support for the Steering Committee, the Internal
Advisory Board and communication with the NIH. Additional administrative duties of the Core include:
administrative support for the selection process of research base membership, maintenance of financial
records and fiscal accountability of the Center, coordination the development of annual reports and renewal
applications for the Center, supervision of purchasing statements of Center budgets for distribution to Center
participants and coordination of these data with the University’s Grants and Management office, and the NIH.
The Administrative Core will facilitate the Directors’ activities as scientific overseers of the Center, particularly
with respect to the administration of the Biomedical Research Cores, Enrichment Program and Pilot and
Feasibility Projects. It will also plan and organize Center seminars and symposia, arrange travel and schedules
for visiting speakers, and publicize YCCEH talks to the Yale community and beyond. The Core will prepare for
and organize annual meetings of the Center’s Internal Advisory Board s, facilitate, where possible, material for
presentation, grant applications, and correspondence from YCCEH Core-related activity and support monthly
meetings of the individual teams of investigators for the purpose of promoting collaborations and joint grant
applications. Because it is the face of the YCCEH to the world, a priority of the Administrative Core will be to
maintain/update the YCCEH website that informs all of the members of the Yale community, as well as those
outside of Yale, of the services, seminars, and workshops offered by the Center. The Administrative Core will
also ensure that there is seamless integration of the YCCEH website with the NIDDK Centers website. Finally,
the Core will help leadership assess productivity of YCCEH activities by maintaining records of collaborations
and publications containing data obtained through the use of the Center.

Public health relevance
Project Narrative Administrative Core Yale Cooperative Center of Excellence in Hematology The Administrative Core of the Yale Cooperative Center of Excellence in Hematology (YCCEH) will provide the administrative structure for the YCCEH Activities include organizing activities, maintaining the budget, organizing travel and conferences, and keeping the website of the YCCEH up to date.